STUDIES OF MATERNAL AND NEONATAL IMMUNITY

[unreadable] DESCRIPTION (provided by applicant): The failure of the trophoblast to express MHC antigens is believed to be essential for survival of the fetus during pregnancy. It is therefore likely that strong evolutionary pressures to preserve reproduction would develop tight overlapping regulatory controls of these genes. We have shown that in trophoblasts, class II expression is mediated by at least two control mechanisms involving repression of class II transactivator transcription and an upstream negative regulatory element [NRE]. Fusion of B cells expressing class II with trophoblast cells has been reported to result in silencing of the CIITA gene in the heterokaryon suggesting a repressor in the trophoblast. Repression of class II in trophoblast cells has been postulated to result from several candidate inhibitors of CIITA transcription [Blimp-1, TGF-beta]. We have demonstrated that low concentrations of deacetylase inhibitors [DAIs] activate class II and costimulatory molecules on trophoblast cells without demonstrable CIITA. DAIs at higher concentrations induce cell cycle blocks and apoptotic cells expressing class II, CD4O, CD8O and CD86. This grant will explore the possibility of a CIITA independent pathway of class II activation mediated by epigenetic agents, such as acetylation and methylation, in trophoblast cells and attempt to further define the underlying molecular pathways. The physiological relevance of these findings to the ability of the fetal trophoblast cells to initiate an immune response will be investigated. The expression of MHC and other key immune genes will be evaluated on apoptotic trophoblast cells produced by DAIs and similar other toxic agents and on exosome derived trophoblast cell lines and on fresh murine trophoblast cells. Hopefully, these studies will enhance our understanding of the general mechanisms that regulate class II expression and certain other immune genes on trophoblast cells. This work may also have application to areas of clinical relevance, such as abortion, autoimmunity and cancer.